Individualized Immunosuppression for Kidney Transplant Recipients

PROJECT SUMMARY/ABSTRACT
Dr. Sunjae Bae is an Assistant Professor of Surgery and Population Health at NYU Grossman School of
Medicine. He completed his PhD in epidemiology and Master’s in biostatistics at Johns Hopkins Bloomberg
School of Public Health. Prior to his research training, he received his medical education at Kyung Hee
University and practiced as a clinician. His previous research has focused on immunosuppression and clinical
outcomes after kidney transplantation (KT), with the support from the American Society of Nephrology and
Mogam Science Scholarship Foundation.
Dr. Bae’s long-term goal is to help >230,000 KT recipients live longer and healthier by creating an evidence-
based, patient-centered tool for determining the ideal immunosuppression regimen. Lifelong
immunosuppression is a defining feature in the care of KT recipients. Immunosuppression is the primary
intervention to prevent acute rejection; however, it causes various side effects, notably 2.1- to 6.2-fold risk of
infections, cancers, and cardiovascular diseases, which collectively account for >65% of deaths in this
population. Since the risks of acute rejection and immunosuppression-related side effects are unique in each
recipient, the selection of the immunosuppression regimen should be individualized according to the recipient’s
unique risk profile.
The transplant community has long recognized the importance of immunosuppression individualization.
However, there is little scientific evidence guiding how it should be done, mainly due to 3 methodological
challenges. First, traditional analytic methods are ineffective in providing individualized predictions of the risks
and benefits after immunosuppression. Second, a method to objectively assess the risk-benefit balance from
patients’ perspectives is lacking. Lastly, the new individualization protocol must be clinically relevant. However,
given the lack of consensus on how the individualization should be done, the relevance of a new protocol
cannot be assessed objectively.
This K01 Mentored Research Scientist Development Award will enable Dr. Bae to expand his research skillset
and lay the groundwork for addressing these 3 challenges. We propose the following approaches. First, we will
create a machine learning-based individualized risk prediction model that can process statistical interactions
efficiently and transparently. Second, we will conduct interviews and paired-comparison surveys to quantify the
patients’ viewpoints on the risk-benefit balance, e.g., how much reduction in acute rejection is worth risking a
10% increase in type 2 diabetes. Third, we will survey KT clinicians to characterize their clinical practice and
perspectives on individualization. Dr. Bae will enhance his analytical skills and expand his domain knowledge
through didactic coursework in patient-oriented research methods and implementation science, and research
mentorship by a team of multidisciplinary experts committed to Dr. Bae’s career development.

Public health relevance
PROJECT NARRATIVE Immunosuppression is the key intervention that makes kidney transplantation possible, while it is also a significant risk factor for infection, cancer, and cardiovascular diseases, the top 3 causes of mortality among kidney transplant recipients. Immunosuppression individualization will improve the health and longevity of kidney transplant recipients by maximizing the protection against acute rejection while minimizing immunosuppression-related side effects; however, the scientific evidence to guide this practice is severely lacking. This grant will allow us to lay the groundwork for an evidence-based, patient-centered, and clinically relevant framework for immunosuppression individualization.